Columbia University/Aga Khan University Global Network Research Unit

Project Summary:
The Aga Khan University/Columbia University (AKU/CU) Global Network Research Unit is applying to continue
its membership in the Global Network for Women's and Children's Health Research (Global Network [GN]). At
CU, the project is located in the Dept. of OBGYN and at AKU within the Dept. of Community Health Sciences
(CHS). To date, our site has been among the most productive in the GN. We have fully participated in all aspects
of the GN from developing successful concepts for single site and common protocols to leadership on GN
committees. We have acquired non-GN funds both to support GN multisite projects and to strengthen the Dept.
of CHS at AKU. We have proven access to large urban and rural populations and have successfully performed
hospital-based and community-based studies. We are the only site to have participated in every common
protocol. We have contributed more clusters to the GN Registry and cluster-randomized trials than any other
site. Our follow-up rates and the quality of our data are excellent. Over the 17 years in the GN, we have enrolled
more than 230,000 women and children in GN projects. In the next 5 years, we plan to continue or surpass this
level of engagement as detailed below. As part of the GN, we will conduct multi-center trials of interventions for
pregnant women, newborns and children to reduce their mortality and morbidity in Pakistan and other low-
resource countries. We also plan to continue to maintain a population-based registry of pregnancies and their
outcomes in Pakistan, to measure trends and factors associated with those outcomes and to compare risk factors
and outcomes to other GN sites. We will continue being a leader among the GN sites in protocol development,
subject recruitment, data quality and obtaining outside funding for GN projects and continue to stimulate the
development of Pakistani researchers and promote collaborations between AKU researchers and those from CU
and other US sites. We will continue to attract new Pakistani and US investigators to global maternal and child
health research by systematic mentoring of junior investigators and recruiting senior scientists from related fields,
and to continue enhancing the research environment at AKU by providing high-quality administrative, financial,
statistical and research support services within a scientifically stimulating multidisciplinary setting. We also will
continue to support government endeavors to strengthen the health system in our research site by facilitating
training on new cost-effective interventions suitable for countries with limited resources. Because of the many
strengths of our research team and its dedication to improving the health of women and children in low-resource
settings, as well as its long history of collaboration within the GN and with many entities in Pakistan, we strongly
believe that the goals described above will be achieved almost immediately and continue indefinitely, and that
the AKU/CU site will continue to be a leader in the GN. As a member of the GN, the AKU/CU site will continue
to participate in all aspects of the GN including meeting participation, membership in committees, seeking outside
funding, initiating new projects, participating in all studies and using GN data to produce important publications.

Public health relevance
The current and future research done by the Global Network with substantial leadership and contributions from the Aga Khan/Columbia site have provided insight into adverse pregnancy outcomes in low and low‐middle income countries and led to important changes in public health practice. Studies performed to date include those focused on factors associated with adverse pregnancy outcomes, near miss maternal mortality, causes of fetal, neonatal and maternal mortality and several multi‐country randomized trials including the use of lower level providers to provide newborn resuscitation and ultrasound use during prenatal care and pre‐ delivery corticosteroids to enhance fetal maturity. The research of the Global Network has influenced the adoption of various interventions aimed at improving pregnancy and child health outcomes in low and low‐middle income countries and we believe our current study of low‐ dose aspirin to reduce the rate of preterm birth, and future large trials undertaken by the Network will have similar impact.